Retrosplenial representations of space and hippocampal circuitry underlying reorientation

Project Summary/Abstract
Reorientation, the navigational process of regaining one’s bearings when lost, is critical for survival and is
impaired in several neurodegenerative diseases. Since surface layouts of navigable space tend to be stable over
time, lost navigators initially use the geometry of the environment to reorient, despite the presence of directionally
informative featural cues, such as visual landmarks, sounds, and/or textures. However, geometric strategies
lead to errors in geometrically equivalent locations (e.g., opposite corners of a rectangle). Over repeated
exposures to a reorientation context, lost navigators form associations of featural cues and a goal-location, and
reorientation becomes guided by features. The hippocampus is well-established for its role in spatial memory,
and its cells integrate both geometric and featural cues of the environment. During reorientation, these cells align
to the geometry of the environment. However, it is unclear how the hippocampus modulates the relative salience
of geometric and featural information during reorientation as animals learn the directional value of featural cues.
The retrosplenial cortex (RSC) is a visuospatial processing region that evaluates landmark stability, an inherent
property of environmental geometry, and contains cells that are responsive to places, borders, and head-
direction on the horizontal plane. Moreover, the RSC is important for environmental learning and lesions to this
area impair reorientation. Additionally, the RSC receives monosynaptic, long-range inhibition from GABAergic
cells in hippocampal area CA1, a projection that may serve to inhibit the use of geometry during reorientation
once associations of featural cues are formed. The goal of this proposal is to investigate how environments are
represented in the RSC at the population and single-cell level and the functional role of hippocampal GABAergic
projections to RSC during reorientation. To address these questions, this proposal will investigate three aims: 1)
Are RSC cell population and single-unit activities correlated with environmental geometry and does RSC activity
predict reorientation behavior? This will be assessed using calcium-imaging and single-unit recordings of RSC
cells in freely moving mice during reorientation. 2) Does activity of hippocampal GABAergic projections to RSC
correlate with behavior in reorientation by features? This will be assessed using pathway-selective calcium-
imaging of hippocampal GABAergic cell bodies projecting to RSC during reorientation. 3) Does activation of
hippocampal GABAergic projections to RSC impair behavior in reorientation by geometry? This will be assessed
using pathway-selective optogenetic activation of hippocampal GABAergic terminals in RSC during reorientation.
Under this fellowship, the applicant will continue her training in in vivo electrophysiology and calcium-imaging,
honing her skills as an experimentalist. The applicant will also strengthen her computational and analytical skills
to address research questions from multiple perspectives. Elucidation of neural mechanisms underlying
reorientation will provide critical information about navigational cognitive architecture.

Public health relevance
Project Narrative Reorientation is a universal navigational process that is impaired in neurodegenerative diseases, such as Alzheimer’s disease. This proposal seeks to understand how spatial representations in the retrosplenial cortex contribute to this process and how these spatial representations are inhibited for more efficient reorientation in the healthy brain. Elucidation of the spatial representations and neural circuitry underlying reorientation will provide therapeutic approaches for clinical populations impaired in this process.